Intermittent and daily smoking; a comparison between mechanisms

PROJECT SUMMARY Tobacco use is the leading cause of preventable illness and death in the United States. Despite the well-known negative health consequences of smoking, and substantial prevention and intervention efforts, many individuals continue to smoke. Our prevention and intervention efforts have been recently challenged by the dramatic changes in smoking behavior from daily smoking (DS) to intermittent smoking (ITS). DS is mostly associated with tolerance and craving and is driven by automatized routines leading to continuous consumption, and characterized by loss of voluntary control. By contrast, ITS is associated with social motives, it is more dynamic, characterized by intermittent periods of smoking and abstinence, and uniquely susceptible to social influences. Despite the lack of nicotine dependence, ITSs have difficulty quitting with increased risk for smoking-related health consequences. Because, ITS cannot be explained by nicotine dependence, it requires a different perspective that takes into account its social, dynamic aspects in order to understand the mechanisms responsible for its initiation and maintenance. In the current proposal we integrate research on smoking with advances in motivation and self-regulation and propose a novel perspective that identifies potentially unique mechanisms underlying ITS compared to DS. We propose that by contrast to DS which is characterized by craving, automatized routines enacted in the presence of smoking cues, and lack of control, ITS is an active process initiated as a means to social goals activated by social cues in the absence of any nicotine-dependence symptoms such as craving. The activation of the goal that smoking serves may result in the inhibition of inconsistent goals (e.g. health) and may allow the distortion of the risks associated with smoking. This mechanism might explain initiation and maintenance of smoking despite negative consequences. Finally, given that ITS is not compulsive and habitual, inhibition of health-related goals may require executive control. From this perspective, efficient executive control may perpetuate, rather than prevent ITS. In line with this perspective we propose an experimental study to compare DSs and ITSs on smoking-relevant outcomes in the presence of social vs. smoking cues.

Public health relevance
PROJECT NARRATIVE The current applications aims to understand the unique mechanisms underlying smoking behavior in intermittent compared to daily smokers. Empirical support for the mechanisms underlying intermittent smoking represents a crucial first step to refine our prevention and intervention strategies to target not only nicotine-dependent smokers, but also smokers who might not exhibit signs of dependence and who might therefore not considered themselves smokers but who might still suffer serious consequences from smoking.